CLINICAL TRIAL: METHAMPHETAMINE EFFECTS IN BRAIN DOPAMINE ACTIVITY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this study is to investigate how much damage methamphetamine does to the human brain and to evaluate whether the brain can recover after a drug free period of about six to nine months.